Examining transactional relationships between sensor-derived alcohol use data and acute suicide risk in daily life

PROJECT SUMMARY/ABSTRACT
Over one million people receive treatment for alcohol use disorder (AUD) annually. Community re-entry
following
potentially
residential AUD treatment is a critically high-risk period for suicide, with residential AUD treatment
reflecting a final attempt for help prior to suicide.Most people also return to alcohol use within 30
days of discharge, with acute use of alcohol being a foremost risk factor for suicide. Therefore, determining the
causal timing of the proximal relation between acute use of alcohol and suicide risk during community re-entry
has high significance for preventing suicide. There is also a need to identify psychological mechanisms
underlying the association between acute use of alcohol and suicide risk to inform preventative interventions.
The proposed study will assess time-varying, longitudinal changes in acute use of alcohol and suicide risk
during community re-entry. This will inform evidence-based digital tools to detect and intervene on suicide risk.
Thisstudy significantly advancesresearch by using ecological momentary assessment (EMA) and a
transdermal alcohol sensor (BACtrack Skyn) to test temporal and proximal relations between alcohol use and
suicide risk, as well as underlying psychological mechanisms, in the 30 days immediately following residential
AUD treatment (N=300). Suicide risk fluctuates substantially—even within timescales of hours. Thus, studies of
acuteuse of alcohol and suicide riskrequire methods that can track experiences closely over time, rather than
relying on retrospective or cross-sectional assessments. Ecological monitoring tools can accurately record
suicide risk in daily life, proximally to when it occurs. Transdermal alcohol sensors passively collect clinically
relevant and unique information on acute use of alcohol not otherwise available through self-report. Yet, no
research has applied these methods to study the relation between acute use of alcohol and suicide risk.
Aim 1 examines aspects of sensor-derived alcohol use (i.e., intoxication, volume, and pace) in relation to
EMA-derived suicide ideation. Aim 2 tests underlying psychological mechanisms (i.e., psychological distress,
impulsivity, and cognitive constriction) in the momentary relations between aspects of sensor-derived alcohol
use and EMA-derived suicidal ideation. Aim 3 elucidates whether risk derived from sensor-derived alcohol use
in daily life during community re-entry will predict suicidal behavior at 6-month follow up above and beyond
subjective measures of alcohol use collected from clinical measures at baseline and with EMA during re-entry.
The proposed research fills important gaps regarding time-sensitive proximal predictors and underlying
mechanisms of alcohol-related suicide during the high-risk and understudied period of community re-entry.
This work is important, timely, and innovative. Developing evidence-based tools to monitor, detect, and
intervene on suicide risk during community re-entry has high significance for preventing suicide.

Public health relevance
PROJECT NARRATIVE Acute use of alcohol is a leading contributor to suicide. Community re-entry following residential alcohol use disorder (AUD) treatment is markedby a significant increase in suicidal ideation and behavior, and is the most common treatment setting where individuals with AUD were last seen before premature death by suicide. Evaluating proximal associations between acute use of use and suicide risk, as well as identifying underlying psychological mechanisms, during community re-entry will provide the necessary groundwork for developing an evidence-based digital tool to monitor, detect, and intervene during the early stages of suicide risk.